Molecular Mechanisms of Telomere Length Homeostasis

Not Applicable, no changed by the proposed supplement activities.

Public health relevance
Not Applicable, no changed by the proposed supplement activities.